Decoding the molecular logic of TPR cochaperones

PROJECT SUMMARY / ABSTRACT
Tetratricopeptide repeat (TPR) cochaperones are a diverse family of adaptor proteins that cooperate with the
heat shock protein (Hsp) 70 and Hsp90 chaperone systems. These modular proteins are composed of their
eponymous TPR domain, which mediates complex formation with the Hsps, and an enzymatic or scaffolding
domain that can aid the chaperone in client recruitment or quality control. The importance of these accessory
functionalities in maintaining protein homeostasis is evidenced by the implication of TPR cochaperones in a wide
range of diseases from neurodegeneration to cancer. However, our understanding of the molecular mechanisms
that underpin substrate recognition by these proteins is incomplete. In particular, there is increasing evidence
that TPR domains can recruit proteins beyond their canonical chaperone binding partners, and the significance
of this alternative pathway is currently unknown. In addition, it is generally difficult to establish substrate
relationships for TPR cochaperones given the compensation that can occur within the protein homeostasis
network following genetic perturbations. Development of chemical probes that can specifically inhibit TPR
cochaperone complexes with high temporal resolution is therefore highly desirable. The effort to develop such
tools would be greatly augmented by an understanding of which molecular features of TPR domains can be
exploited to achieve high affinity and selective binding. The objective of this proposal is to develop a chemical
toolkit that helps solve both of these problems by decoding the molecular logic of interactions between TPR
cochaperones and their substrates. In my first aim, I will develop chemical proteomic tools to profile the binding
of TPR cochaperones and measure changes in substrate association in response to different stimuli. These
probes will also enable the specificity of TPR inhibitors to be assessed in a rapid fashion. In my second aim, I
will refine a predictive scoring function in order to comprehensively identify substrates that are autonomously
recognized by the E3 ligase CHIP. In exploring the molecular determinants of CHIP's interactions with its
substrates, I will also identify features that enable an individual TPR cochaperone to bind ligands that are distinct
from its related family members. This work is significant because it will provide fundamental insights into the
rules governing the biology of TPR cochaperones, and will serve as the bedrock for future substrate discovery
and probe development efforts across this protein family. The proposed studies will also provide a training
environment that is ideally suited to my goal of becoming a translational chemical biologist, with opportunities to
gain experience with state-of-the-art techniques while also cultivating my ability to conduct research
independently.

Public health relevance
PROJECT NARRATIVE Tetratricopeptide repeat (TPR) cochaperones are a diverse family of adaptor proteins that augment the ability of the heat shock protein (Hsp) 70 and Hsp90 systems to facilitate protein quality control, and are implicated in a wide range of diseases, notably neurodegenerative disorders. However, our understanding of the molecular mechanisms that underpin the function and regulation of these proteins is incomplete, in part due to a lack of chemical tools with which to study them. The integrated chemical biology approach proposed herein will shed light on the structure-function relationships of these proteins and facilitate the development of specific probes to study their biology in depth, providing a powerful framework for unraveling the disease associations of this protein family.